Validation of a pediatric thrombosis risk assessment model and characterization of bleeding in hospitalized children through the Children's Hospital Acquired Thrombosis (CHAT) Consortium

PROJECT SUMMARY/ABSTRACT
Venous thromboembolism (VTE), a serious and life-threatening condition, has increased in incidence for
hospitalized pediatric patients by 70-200%. This has led to increased morbidity, mortality and longer
hospitalizations, and is thought to be due to more effective care of children with serious and life-threatening
disorders. Unfortunately, it is unclear which children are at the highest risk of hospital acquired (HA) VTE and
how to prevent these events due to many studies being single center with small case numbers. This study
addresses the critical need to identify children at a high risk of HA-VTE using a risk assessment model
(RAM), but a low risk of bleeding. This cohort will be used as the target population for trials evaluating the
efficacy and safety of prophylactic anticoagulation in order to progress towards the long term goal of HA-VTE
prevention in children. The overall objectives of this study are to (1) prospectively validate a pediatric HA-VTE
RAM created through Dr. Jaffray’s multi-center Children’s Hospital Acquired Thrombosis (CHAT) Consortium
using a case-control study design and electronic medical record review (EMR); (2) evaluate the incidence and
characterization of bleeding in hospitalized children on and off anticoagulation through EMR review; and (3)
explore barriers to provider engagement with RAM implementation by conducting focus groups and semi-
structured interviews of inpatient medical teams using qualitative thematic analysis strategies. To achieve
these research aims, Dr. Jaffray has the immediate career goals to obtain new knowledge, skills, and
experience that will allow her to (1) analyze data from large datasets from multicenter studies and build and
validate risk models through multivariate analysis; (2) develop qualitative research skills to design and analyze
focus groups and semi-structured interviews; and (3) acquire the knowledge to plan and conduct randomized
controlled trials. Achieving these career goals will support her long term career goal of becoming an
independently funded, leader in the effort to determine efficacious and safe VTE prevention strategies in children
through multicenter randomized controlled trials. Dr. Jaffray will accomplish her research and training aims with
the support of her primary mentor, Dr. Guy Young (pediatric thrombosis clinical research), and co-mentors,
Dr. Neil Goldenberg (pediatric clinical trial research), Dr. Ernest Amankwah (biostatics), Dr. Neil Zakai (adult
thrombosis clinical research) and Dr. Elizabeth Burner (qualitative research). Dr. Jaffray’s plan for career
development is enhanced by the outstanding research environment at Children’s Hospital Los Angeles and The
University of Southern California, which provides junior faculty members with numerous didactic and training
opportunities designed specifically to facilitate the transition to research career independence. By completing
her research and training aims, Dr. Jaffray will take the first necessary step in identifying children at high risk of
HA- VTE who may safely benefit from prevention strategies and subsequently reduce the incidence of pediatric
VTE.

Public health relevance
PROJECT NARRATIVE Hospitalized children who develop a venous thromboembolism (VTE), a blood clot in the deep veins or pulmonary vasculature, have an increased risk of morbidity from long term pain and venous insufficiency, as well as increased mortality. The current lack of established methods for assessing VTE risk or applying safe and effective VTE prevention strategies as a standard component of hospital admission for children has led to the continuously increasing incidence of hospital-acquired VTE. Completing the aims of this study will contribute to the NIH mission to apply scientific knowledge to enhance health, lengthen life and reduce illness and disability in children through establishing a validated pediatric VTE risk assessment model, identifying barriers to hospital staff implementing risk models and determining the incidence and characterization of bleeding in hospitalized children to create safe thromboprophylaxis methods.